Flow Cytometry

ABSTRACT
The Flow Cytometry (FC) Core offers centralized expertise and instrumentation in Flow Cytometry and
Cell Sorting to investigators of the Cancer Center. The extensive user support includes a) assisting in
planning, executing, and analyzing Flow Cytometry experiments; b) daily instrument setup, maintenance,
quality control and performance monitoring; c) facilitating instrument access through implementation of
adequate polices with an easy and reliable scheduling system; d) offering several software site licenses
for high-end Flow data analysis; and e) extensive training and education options. Instrument based-services
include operator-assisted cell sorting in five multiparametric FACSAria high-speed cell sorters, useroperated
cell sorting in two multiparametric FACSAria cell sorters, and user-operated analysis in five
high-end multiparametric analyzers (two LSRII and three LSR Fortessa) and a four-parameter FACSCalibur.
Altogether, the availability of high-end instrumentation and highly qualified staff with experience provide
investigators of the Center access to highly purified cell populations, and the possibility to characterize cell
subsets involved in the processes of tumor development, which can ultimately lead to improved cancer
diagnosis and therapy.